Role of Angiotensin II in Bladder Dysfunction

Interstitial cystitis/bladder pain syndrome (IC/BPS) is associated with increased voiding frequency, nocturia, bladder fibrosis, and chronic pelvic pain. It affects between 2.5 to 6.7% of women in the United States. Current treatment options are ineffective for all patients and are associated with detrimental side effects. One understudied signaling peptide/hormone in IC/BPS is angiotensin II (Ang II). In addition to its role in vasoconstriction, water retention, and stress response, Ang II contributes to several diseases by promoting oxidative stress, proinflammatory cytokine release, and fibrosis, resulting in increased nociception and sensory sensitivity. However, compared to other organ systems (cardiac, kidneys, and lungs), relatively little is known about the function of Ang II signaling in the bladder under pathophysiologic conditions. There are several intriguing links between IC/BPS pathology and angiotensin signaling. 1) IC/BPS patients have increased infiltration of mast cells, which represent a source of increased renin and Ang II. 2) IC/BPS patients and animal disease models have increased bladder oxidative stress, and angiotensin signaling increases ROS production.
3) IC/BPS patients have increased expression of inflammatory mediators, which can be released by Ang II downstream signaling. 4) Fibrosis is observed in patients and animal models of IC/BPS, and Ang II signaling has been linked to fibrosis in heart, lungs, liver, and kidneys. Given the foundation of IC/BPS research demonstrating increases in local mast cells/macrophages, oxidative stress, inflammatory mediators, fibrosis, and the wealth of literature describing similar Ang II molecular signaling events in other tissues, we believe it is essential to further explore the role of Ang II in bladder diseases. We hypothesize that Ang II signaling plays a vital role in developing inflammation, oxidative damage, and fibrosis associated with an animal model of bladder dysfunction. We will test this hypothesis by dissecting the contribution of angiotensin type 1 receptor (AT1R) (Aim 1) and angiotensin type 2 receptor (AT2R) (Aim 2) to the pathophysiologic symptoms of oxidative stress, the release of proinflammatory molecules, and fibrosis associated with a mouse model of IC/BPS-like symptoms. We will use pharmacological and transgenic approaches to determine the cell type expression of AT1R and AT2R in the bladder, how expression levels may change under disease conditions and their importance in developing and maintaining disease symptoms. This proposal will help determine the role of Ang II in IC/BPS, potentially opening this disease to treatment with the widely available and safe angiotensin signaling inhibitors, which would have a substantial impact on patient treatment options and quality of life.

Public health relevance
Interstitial cystitis/bladder pain syndrome (IC/BPS) affects millions of Americans, and current treatment options are ineffective for many patients. This project aims to determine the role of angiotensin signaling in developing and maintaining disease symptoms of IC/BPS using animal models. These results could open up new FDA- approved treatments with widely available and safe angiotensin inhibitors, substantially impacting patients’ quality of life.